Targeting BRCA1/2-deficient cancers with folate and vitamin C

Project Summary
BRCA1 and BRCA2 are tumor suppressor genes frequently inactivated in cancer, particularly in ovarian and
breast cancers. Despite recent advances in therapy, many patients with BRCA1/2-deficient cancers eventually
die of the disease and, therefore, new treatment options are needed. The goal of this proposal is to develop a
novel targeted therapy against BRCA1/2-deficient cancers that combines high doses of tetrahydrofolate (THF)
and vitamin C (VC) to generate metabolic genotoxins in cancer cells. The rationale of the proposed strategy
stems from the recent discovery that high doses of THF, the active form of folate, oxidize generating the potent
crosslinker formaldehyde (FA), which kills cells deficient in DNA crosslink repair such as BRCA1/2-mutant cells.
In addition, preliminary data show that vitamin C (VC) promotes the selective killing of BRCA1/2-deficient cells
by THF. VC and THF synergize at generating reactive oxygen species (ROS), suggesting formaldehyde and
ROS generation might drive the cytotoxic effects in BRCA-mutant cells. In contrast, VC reduces THF toxicity in
normal tissues in mice, which allows the administration of higher doses of THF. Furthermore, treatment with THF
and VC in combination prolongs the survival of mice with BRCA1-mutant tumors. Based on these findings, this
proposal aims to: (1) Understand the mechanism of selectivity of the vitamin combination against BRCA1/2-
deficient cells, by using isogenic cell lines, metabolic tools, DNA damage assays and molecular and cell biology
techniques. (2) Characterize the interaction between THF and VC in mice, by employing metabolomics,
ultrasensitive mass-spectrometry analysis of DNA adducts, immunohistochemistry and infrared microscopy. (3)
Assess the efficacy of THF/VC therapy against BRCA-mutant tumors in mice, by using orthotopic syngeneic
models of ovarian and breast cancer and measuring the impact of THF/VC in tumor growth and overall survival.
By using state-of-the-art tools and cancer models, this project could provide the foundations of a novel
therapeutic strategy for the treatment of BRCA1/2-mutant cancers. In addition, it could support an unconventional
approach of harnessing metabolism for cancer therapy that manipulates metabolism to generate metabolic
genotoxins in cancer cells.

Public health relevance
Project Narrative The proposed project aims to develop a novel therapeutic strategy that combines high doses of two vitamins, folate and vitamin C, to selectively kill BRCA1/2-deficient tumors by generating metabolic toxins in cancer cells. The findings from this research could rapidly progress to clinical trials and validate an unconventional approach of harnessing metabolism for cancer therapy.